Biodemography Over the Life Course Conference Series

PROJECT SUMMARY
This proposal requests five years of funding to support the initiation of an annual conference,
Biodemography Across the Life Course, to be held at the University of Wisconsin-Madison from
2020-2024. The two-day conference will combine training and research presentations that focus
on the integration of biomarker (including genetics) data with social science theory and methods
that are well grounded in life course theory. Key goals of this proposal are: (1) to provide a venue
for the leaders in the areas of life course analysis (sociology, economics, demography,
epidemiology, etc) and genetic and biomarker analysis (epidemiology, genetics, microbiology,
biostatistics and informatics, etc) to share their theoretical, methodological, and substantive
knowledge with one another; (2) to produce new and interdisciplinary projects and publications in
the area of “life course biodemography”; (3) to identify new issues that are, to date, understudied
in this area and (4) to provide training in datasets suitable for life course biodemographic analysis.

Public health relevance
PROJECT NARRATIVE The conference has a substantive focus on health conditions, health behaviors, morbidity, and mortality with a focus on life course determinants. This conference will integrate biology/genetics and social science to provide new insights into long standing public health issues. The conference combines hands-on training opportunities in hypothesis generation, testing, and data analysis with cutting edge research presentations and interdisciplinary discussions.